Integrin activation during neutrophil adhesion and vascular inflammation

Neutrophils, which are essential for host defense against bacterial and fungal infections, induce
inflammation following tissue necrosis or ischemic injury. If not properly resolved, neutrophilic
inflammation is the driving force behind a plethora of human inflammatory diseases. Neutrophils arrive at
the site of injury from the bloodstream by first rolling and then arresting. Arrest is triggered by chemokines
that induce the high-affinity conformation of ..2 integrins. Two FERM domain proteins, kindlin-3 and
talin-1, are required for neutrophil arrest. It is well known that talin-1, an adaptor protein that binds the
actin cytoskeleton, activates integrins by binding and altering the topology of the .. transmembrane
domain. We recently reported that kindlin-3 is recruited to the plasma membrane through its pleckstrin
homology domain prior to neutrophil arrest. However, the mechanism underlying neutrophil spreading and
the role of kindlin-3 in this process are poorly understood. Moreover, how kindlin-3 cooperates with talin-1
to activate integrins and whether kindlin-3 also functions as an adaptor protein by directly binding to actin
are completely unknown. Our overarching hypothesis is that, during neutrophil spreading, both kindlin-3
and talin-1 are simultaneously recruited to the plasma membrane, where kindlin-3 organizes high-affinity
integrin activation. To test this hypothesis, we generated reporter mouse lines for simultaneous detection
of ..2 integrin activation and imaging of kindlin-3 and talin-1 in mouse neutrophils. In Aim 1, we will test the
hypothesis that kindlin-3 organizes a ring of clustered high-affinity ..2 integrins during neutrophil spreading
under flow conditions; in Aim 2, we will test the hypothesis that kindlin-3 regulates integrin activation by
directly binding to the actin cytoskeleton; and in Aim 3, we will determine the role of ..2 integrin activation
in ischemia-reperfusion injury (IRI). The proposed research is conceptually innovative and highly
significant because it will resolve the enigma of how kindlin-3 organizes high-affinity integrin activation
and define the role it plays in IRI-induced inflammation. Successful completion of this proposal will
establish molecular mechanisms of integrin activation and provide mechanistic insight into neutrophil
spreading and vascular inflammation.